Mechanisms of chromosome damage repair in human cells

PROJECT SUMMARY
DNA repair by homologous recombination (HR) in tumor cells accelerates the development of resistance to
chemo- and radiotherapy and leads to the recurrence of disease. Hence, inducing HR deficiency in HR-proficient
tumors is a promising strategy to increase the efficacy of DNA-targeted therapies. Yet, we still do not know which
stage of the HR reaction is the most sensitive to inhibition and consequently the most promising to target.
However, inhibition of HR pathway intermediates during synapsis and strand invasion may be particularly
effective.
The long-term goal of our study is to lay the groundwork for the development of novel HR-directed anti-
cancer therapeutics. The central hypothesis of our project is that human cells have evolved multiple pathways
of strand invasion. The rationale for this project is that a detailed understanding of the molecular mechanisms of
the multiple pathways of strand invasion is likely to offer a strong scientific framework whereby new strategies to
cancer therapy can be developed. The overall objectives in this application are to (i) elucidate the molecular
mechanisms of the multiple pathways of strand invasion in HR in human cells, and (ii) determine the steps in
these pathways in which the HR functions of the RAD51 activators RAD51AP1, RAD54L, and RAD54B intersect.
The central hypothesis will be tested by pursuing two specific aims: 1) Dissect the non-epistatic and epistatic
relationships between RAD51AP1, RAD54L, and RAD54B; and 2) Determine the functional roles of the
RAD51AP1-RAD54L and RAD51AP1-RAD54B protein complexes. Under the first aim, isogenic human cancer
cell lines will be used to determine the phenotypic consequences of RAD51AP1, RAD54L and/or RAD54B
deletion. Proven knockout strategies and assays to evaluate the effect that loss-of-function has on cytotoxicity,
genome stability, replication and recombination will be employed. For the second aim, biochemical assays of
strand invasion utilizing nucleosome-free and nucleosome-containing DNA substrates will be carried out, and
mutants defective in protein complex formation will be tested for complementation in cell survival assays.
The objective of this Administrative Supplement is to obtain the possibility to replace defective and
outdated equipment necessary to achieve the desired purity of the proteins tested in our biochemical
investigations within Aim 2 of the parent award.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it contributes to laying the groundwork for the development of a new strategy to treat cancer by simultaneously utilizing DNA-targeted genotoxic therapy and the inhibition of critical proteins in a DNA damage repair pathway that is facilitated by homologous recombination (HR). HR in tumor cells is associated with accelerated resistance to chemo- and radiotherapy, and with recurrence of disease. The research proposed here aims to identify promising target molecules for inhibition in HR and, as such, is relevant to the NIH’s mission that pertains to increasing our understanding of the biological processes that will lead to advances in the treatment of disease.